Core Grant For Vision Research-Administrative Core

Administrative Core Project Summary/Abstract
This portion of the application describes the Administrative Core of the P30 Core Grant for Vision Research at
Schepens Eye Research Institute (SERI). The Administrative Core provides the organizational structure to: (i)
coordinate and integrate the activities of the resources; (ii) determine the distribution and utilization of funds;
(iii) ensure equitable usage of the service cores; (iv) evaluate the core services; and, (v) revise the service
corps as user needs and/or technology evolve. The PI, Dr. Patricia A. D’Amore, directs the Administrative
Core with assistance from her Administrative Assistant, Mr. James Boggie, and the module directors (Drs.
Chauhan, Elze and Argüeso) as well as members of the Steering Committee, which include the Chief Scientific
Officer for Mass Eye and Ear, Dr. Michael Gilmore, and three rotating members of the faculty with qualifying
projects. The Administrative Core will ensure that the core vision scientists use resources of the P30 Core
Grant for Vision Research resources effectively and efficiently.